Engineering picoviruses with defined host range to combat drug-resistant staphylococci

The emergence of antibiotic resistance combined with a paucity of new antibiotics under development
have sparked a renewed interest in phage therapy as a treatment strategy for infectious diseases
caused by common pathogens like Staphylococcus aureus and Staphylococcus epidermidis.
However, several challenges remain before phage therapy can become a viable treatment option,
including the narrow host range of the phages and concerns about genetic mobilization. Most current
therapeutic strategies rely on cocktails of poorly characterized phages with uncertain interaction with
the human microbiome. There is therefore a need for a more rational approach to phage therapy
based on well-characterized components with defined and programmable host specificities.
The bacteriophages of the Picovirinae subfamily of the Podoviridae (picoviruses) are attractive
candidates for therapeutic applications due to their small (<20 kbp) genomes and strictly lytic lifestyle.
The overall objectives of this exploratory/developmental (R21) project are (1) to understand the
determinants for host range and specificity in staphylococcal picoviruses, and (2) to uncover the rules
for manipulating this specificity to enable the rational design of therapeutic phages with tunable host
range. In this proposal we will test our central hypothesis that picovirus receptor binding protein
structures correlate with host cell wall teichoic acid composition. This will be accomplished through a
combination of phage discovery and sequence analysis, cryo-electron microscopy, and CRISPR-
based genome editing, via three specific aims:
(1) Determine the genetic basis for host attachment by staphylococcal picoviruses;
(2) Define the structural determinants for picovirus host range and specificity; and
(3) Engineer phages with altered host ranges.
This work will establish a predictive framework for determining the sensitivity of a pathogen to
a specific set of picoviruses. In doing so, this research will provide a versatile toolkit for the rational
design of therapeutic phages with pre-determined host specificities against pathogenic staphylococci.
This novel approach can also be broadly applied to target other Gram-positive pathogens.

Public health relevance
Antibiotic resistance among staphylococci and other bacterial pathogens has become a global health crisis, and has sparked a renewed interest in the therapeutic use of bacterial viruses (phages). We have identified a group of staphylococcal phages, called picoviruses, that are ideal candidates for phage therapy, due to their small size and strictly lytic lifestyle. In this project, we will determine the requirements for phage attachment to specific staphylococcal pathogens, thereby enabling the rational design of therapeutic phages with predetermined host specificities.